Development of Novel RhoA Nitration Inhibitory Peptides for the Treatment of Acute Lung Injury

ABSTRACT
Acute lung injury (ALI) and acute respiratory distress syndrome (ARDS) manifest with acute lung inflammation
with increased vascular permeability. Treatment of ALI/ARDS patients with low-volume mechanical ventilation is
the only proven therapy for ALI/ARDS, and mortality rates remain unacceptable. Because the syndrome of acute
respiratory failure is so common in the United States and worldwide, especially in the face of relatively new
respiratory viruses such as SARS-CoV-2, ALI/ARDS is an unmet medical need. Novel pharmacological therapies
need to be developed to further improve clinical outcomes in ALI/ARDS patients. RhoA and Rac1 exert distinct
effects on epithelial and endothelial barrier function via selective structural and biochemical modulation of
junctional proteins. Rac1 and RhoA have antagonistic effects on endothelial barrier function in the lung. Rac1 is
required for the assembly and maturation of endothelial junctions, whereas RhoA destabilizes endothelial
junctions by increasing the isometric tension at the cell membrane, increasing myosin contractility. Our prior
studies have linked RhoA nitration at (Tyr (Y)34) with its activation, endothelial barrier disruption, the disruption
of mitochondrial network dynamics, mitochondrial function, and the activation of NF-kb dependent inflammation.
A strategy has been designed to shield RhoA from nitration at Y34, protect endothelial barrier function, preserve
mitochondrial function, and reduce inflammation during conditions that can cause ALI/ARDS. This strategy
identified a small peptide, NipR1, which protects RhoA from nitration at Y34 and prevents LPS-induced
peroxynitrite attack. NipR1 contains nine amino acids from 31–39 of RhoA fused with the cell-permeable TAT
sequence. Natural peptides have poor absorption, distribution, metabolism, and excretion (ADME) properties
with rapid clearance, short half-life, low permeability, and sometimes low solubility. Thus, in response to this
special NHLBI RFA, a chemical approach will be utilized to identify more potent peptidomimetics of NipR1.
In the R61 phase, we will generate ~100 compounds based on our newly identified pharmacophores and screen
them using both in vitro and in vivo assays in multiple mouse models of ALI. In the R33 phase, we will generate
two optimized NipR1 derivatives, conduct pharmacokinetics/pharmacodynamics (PK/PD) and safety studies,
and confirm therapeutic effects using a pig model of sepsis. We anticipate these studies will allow us to identify
a lead compound with desired in vitro and in vivo characteristics as a novel therapy for ALI/ARDS.

Public health relevance
NARRATIVE/RELEVANCE: Acute lung injury (ALI) and acute respiratory distress syndrome (ARDS) remain common complications of sepsis. There are no effective treatment strategies for sepsis-induced ALI/ARDS, and the mortality rate of patients with ARDS remains unacceptably high. We will design, synthesize, and evaluate a new class of drugs to prevent RhoA nitration and treat ALI/ARDS.